Development and Validation of a Stimulant Use Disorder Severity Scale

PROJECT SUMMARY
Stimulant use and stimulant use disorder (StUD) are major contributors to morbidity and mortality in the U.S.,
disproportionately impacting racial and ethnic minoritized populations. As there is no U.S. Food and Drug
Administration (FDA)-approved medication for StUD, development of medications is a high priority. However,
medication development (and private sector investment) has been hampered by the lack of a practical,
psychometrically sound, clinically significant, and broadly accepted indicator of treatment response, other than
sustained abstinence. Recent FDA guidance for developing medications for treatment of StUD recommends
the development of instruments for endpoints reflecting disease severity. In this project, we propose to
advance development of the novel Stimulant Use Disorder Severity Scale (StUDSS) as a clinical outcome
assessment (COA) qualified by FDA as a Drug Development Tool (DDT), which involves three sequential
stages of submission and review outlined in FDA Center for Drug Evaluation and Research (CDER) guidance.
This work will be conducted at geographically distinct sites in Connecticut and California to enhance validity
across stimulant types and racial/ethnic diverse groups. Development will follow FDA Guidance for patient-
reported outcome (PRO) measures. Preparation and submission of a Letter of Intent (LOI) to the CDER COA
Qualification Program will initiate the qualification process (UG3 - AIM 1). The StUDSS will be administered to
racially and ethnically diverse individuals with StUD (n=40) through 1:1 cognitive interviews to establish content
validity and create a finalized instrument (UG3 - AIM 2). Following completion of milestones during the UG3
phase, and with input and recommendations from CDER, a qualification plan (QP) will be prepared and
submitted to CDER COA Qualification Program (UH3 – AIM 1). The proposed observational study will involve
repeated administration of the StUDSS over a 3-month period among n=300 individuals with StUD across sites
at Yale and UCLA to establish reliability and validity (UH3 – AIM 2). This proposal is informed by rigorous prior
research by our group and others demonstrating relationship between stimulant use outcome measures and
functional outcomes; psychometric characteristics of StUD criteria in DSM-5; and value in measuring change in
characteristics that define StUD. Our team brings together expertise in stimulant use research, scale
development, substance use disorder diagnostic tools, outcome measurement, and the FDA qualification
program. This project will produce: 1) a PRO measuring StUD symptom severity with accompanying content
validity data, 2) a QP accepted in CDER COA Qualification Program, and 3) validity and reliability data from a
racial and ethnic diverse sample. Preparation of a full qualification package (third and final submission stage)
will be dependent on recommendations from QP determination letter and expected to occur after completion of
the project period. A validated PRO measuring StUD symptom severity that becomes accepted by FDA as a
DDT would be of high impact for advancing medication development, treatment research, and clinical care.

Public health relevance
PROJECT NARRATIVE Stimulant use and stimulant use disorder (StUD) are major contributors to morbidity and mortality, yet effective treatment is limited due to the lack of FDA-approved medications. In this project, we plan to advance development and validation of a patient-reported outcome measuring StUD symptom severity that will be submitted to FDA Qualification Program as a Drug Development Tool to accelerate medication development and approval for StUD.